CHAI

ABSTRACT COMMUNICATIONS FOR HEALTH APPLICATIONS AND INTERVENTIONS
The Communications for Health Applications and Interventions (CHAI) SR provides tremendous value and
service to the Center through its development of modern communication techniques for the range of
implementation, clinical, prevention and control research. The services available include behavioral e- and m-
health interventions, qualitative and software design services using adaptive technology. Services for faculty
research projects include: responsive web application, device integration, geofencing, user experience (UX)
and qualitative survey development. The SR was used by more than 30 faculty in fiscal year 2019 which
represented 82% of the total users. CHAI requests $139,365 of a total operating budget of $959,660. The
Center ensure cost-effectiveness and value to the membership through a sustained annual contribution of
approximately $310,000. It is well integrated within the LCCC programs contributed to key studies including:
• PRO-PM: a qualitative study designed to understand patient, caregiver and provider perceptions on
patient reported outcomes during chemotherapy. CHAI supported the research through creation of
interview guides and conduct of over 100 one on one interviews with adult patients receiving
chemotherapy, healthcare administrators, health service researchers, clinicians, and patient advocates
across six cancer centers nationwide.
• PERC: a mixed method study to evaluate feasibility and acceptability of a web based, couple-focused
intervention on prostate cancer symptom management, quality of life and psychosocial factors. CHAI
hosted the web site and supported data collection though a built-in automatic tracking system for times
logged in, time spent on site.
• COMET: a 5 year PCORI-funded project, will involve 1200 patients. The goal of the COMET
(Comparison of Operative vs Monitoring and Endocrine Therapy) trial for low-risk ductal carcinoma in
situ (DCIS). CHAI contributed to the creation of a responsive website that provide accessible,
understandable, and evidence-based information about DCIS, treatment options, including the trade-
offs of each treatment option.
The 9 person CHAI SR includes experts in qualitative analysis, software development graphic design and
project management. CHAI is directed by Deborah Tate, PhD a nationally recognized expert in
communications and behavioral science. The SR uses multiple techniques to test the efficacy of e- or m-
messaging and is careful to assess changes in communication usage for example that many in rural areas
have restricted access to broadband yet higher penetration through mobile devices. Integration with
Community Outreach and Engagement is key in the development of CHAI methods.